Professional Development Core

Abstract/Summary
The Department of Health and Human Services (DHHS) has recognized that underrepresented minority (URM)
faculty receive less mentoring and training than their nonminority peers and that this gap contributes to less
success in clinical and research careers. Thus, there is an urgent need to train qualified underrepresented
minorities (URM) clinician/scientists, RNs, Pharm Ds, basic scientists, behavioral and other health care
professionals, to fill in the demand for researchers that address the health needs of medically underserved
Hispanic and minority communities. The goal of the Professional Development Core (PDC) of the Hispanic
Alliance for Clinical and Translational Research (Alliance) is to design and coordinate trainings, support and
mentoring programs to address the need for more underrepresented minorities in clinical and translational
research and mentoring. The objective of the PDC is to design and coordinate competency based training,
mentoring, and support programs to maximize the productivity of potential CTR researchers and expand the
breadth and scope of CTR in focus areas of prevalent health needs: chronic disease prevention, achievement
of healthy lifestyles, emerging infectious diseases and health disparities. We hypothesize that providing these
activities to researchers with diverse backgrounds and incorporating community leaders to training sessions
will result in the development of a critical mass of URMs researchers addressing health issues in medically
underserved communities. We propose the following Specific Aims: 1. Address the current gap in research
competencies on health and healthcare research in URM-serving institutions through access to a coordinated
and effective educational and support program. Innovative use of technology-based training will expand
opportunities for potential trainees. Support provided for writing publications and developing proposals will
enhance productivity. 2. Address the mentoring gap for URM faculty by developing a robust mentoring program
aimed at fostering relationships that will enhance the productivity and retention of clinical and translational
researchers. The program will focus on two models: developing teams of mentors-mentees and training of
potential individual mentors. Interactions with recognized USA based mentoring programs as well as an in-
house program will enrich the mentors’ training. 3. Address community health needs by training scientists and
community partners jointly to carry out multidisciplinary research responsive to the Hispanic community needs.
The Professional Development Core and the other Alliance’s cores will collaborate in the implementation of a
tailor-made training curriculum.
The impact of the PDC training program is significant because it will support the development of qualified
researchers and mentors that understand, have the know-how, and are interested in addressing the health
needs of a growing US Hispanic and other medically underserved population.